Mechanism of photoreceptor cell degeneration in animal models of retinal diseases

PROJECT SUMMARY
The gene encoding peripherin 2 (PRPH2), is mutated in 3-5% of inherited retinal degeneration (IRD) cases.
PRPH2 variants lead to a spectrum of retinal diseases, including retinitis pigmentosa (RP) and various forms of
macular and pattern dystrophy (PD). These diseases often entail secondary impairments in adjacent tissues like
the RPE and retinal/choroidal vasculature. Despite considerable scientific advancement, the lack of clinically
viable therapeutic options for PRPH2 retinal diseases persists due to several factors including the diverse roles
of PRPH2/ROM1 (retinal outer segment membrane protein 1, a core binding partner of PRPH2) in rods versus
cones, limited genotype/phenotype correlations, extensive variability in disease phenotypes within and
between families, the role of secondary sequalae in disease progression, and the necessity for precise PRPH2
dosage to offset the effects of its haploinsufficiency. PRPH2 plays a crucial role in the formation, maintenance,
and renewal of the outer segment (OS). In its absence rod OSs are not formed. On the other hand, cones form
extended membranous structures that lack evaginations of the lamella but retain function, highlighting the
different roles for PRPH2 in rods and cones. We aim to elucidate the precise role of PRPH2 and ROM1
complexes in OS rim, incisure, and disc/lamella formation, and to expand our knowledge of the PRPH2
interactome with the goal of potentially influencing severity of disease phenotypes. Gaining a thorough grasp of
the mechanisms associated with PRPH2 diseases is crucial for designing effective therapies. The mechanisms
underlying photoreceptor disc morphogenesis are not well understood and are of longstanding interest. To bridge
the gaps in our knowledge, we established mouse models and various therapeutic platforms, enabling us to
evaluate disease mechanisms and test therapeutic strategies for PRPH2 diseases. Our multidisciplinary team is
comprised of leaders in photoreceptor cell and molecular biology, advanced imaging technologies, structural
biology, and non-viral therapeutic formulations and will employ cutting-edge experiments to achieve the following
objectives: 1) Investigate the role of PRPH2 complexes in forming the highly curved, hairpin-shaped disc rim
structures crucial for OS formation. 2) Explore ROM1’s influence on disc rim morphogenesis, particularly in timely
closure of the newly synthesized discs and incisure formation. 3) Identify interacting partners contributing to the
diverse disease phenotypes associated with PRPH2 variants. 4) Investigate mechanisms underlying variability
among patients with identical PRPH2 variants. 5) Develop therapeutic platforms to mitigate severe PRPH2-
associated phenotypes. Understanding these mechanisms is crucial for advancing our knowledge of OS
morphogenesis and the diversity of PRPH2-associated disease phenotypes.

Public health relevance
Project Narrative We aim to investigate PRPH2's independent functions in rods and cones under both normal and diseased conditions to guide therapeutic strategies for mitigating blindness linked to PRPH2 variants. Understanding its function is crucial due to the complex nature of PRPH2-related diseases affecting photoreceptors, RPE, and retinal/choroidal vasculature. Our studies utilize novel mouse models and innovative approaches, leveraging our expertise and tools effectively.